Neural basis of precedence-type sound localization processes

Project Summary
This research project aims to study the neural basis of the precedence-type sound localization processes,
including the Franssen effect. This central computation is key to understanding the normal function of auditory
perception and is a priority area in NIH's hearing research. The precedence phenomena play a critical role in
speech-in-noise, dichotic, and temporal processing, in addition to source location and echo identification.
Illusions such as these are distortions in perception that provide insights into the workings of the auditory system.
The basic precedence effect consists of two ‘identical’ tone bursts are presented with various timing relations
from separate loudspeakers situated on either side; the listener perceives a single ‘fused’ sound as coming from
the speaker that broadcasted the leading sound. The Franssen effect is an illusion where the listener incorrectly
perceives the sound as coming from a loudspeaker that broadcasts a leading short-duration sound pulse with a
fast amplitude rise and slow decay. This happens despite most of the sound originating from a contralaterally
placed lagging loudspeaker producing long-duration sound with a slow onset. The proposed research takes
advantage of the natural preference of a species of gray treefrogs (Hyla versicolor) for slow-rise, long-duration
(SR-LD) sound pulses that represent those used to elicit FE illusions. In choice tests, H. versicolor females
strongly prefer SR-LD sound pulses over the fast-rise, short-duration (FR-SD) pulses of their sister species Hyla
chrysoscelis and approach the transducer broadcasting the former. In aim 1, we plan to conduct behavioral
experiments that take advantage of this natural preference. We hypothesize that subjects will erroneously
approach a loudspeaker broadcasting FR-SD pulses when they precede SR-LD pulses form an orthogonally
placed loudspeaker. In aim 2, we propose to make extracellular recordings from single neurons in the anuran
inferior colliculus (ICan) to stimuli that elicit FE. We hypothesize that FR-SD pulses from a contralateral
loudspeaker suppress neurons selective to SR-LD stimuli. To understand the temporal integration of binaural
excitatory and inhibitory inputs to the ICan, we propose, in aim 3, to examine the role of inhibition in FE. We seek
to utilize a constellation of techniques, including in vivo whole-cell recordings and analytical methods for
estimating inhibition elicited in SR-LD selective neurons by preceding ipsilateral FR-SD stimulus.

Public health relevance
Project Narrative Precedence-type processes can influence sound localization, particularly in complex acoustic environments. The central component of age-related hearing impairment, includes decreased localization dominance, as experienced in the PE illusion. We propose to investigate the neural mechanisms of precedence effect phenomena, including the Franssen effect, in an animal model.